Defining the Role of 5'UTR G-Quadruplex in Transcription and Translation

PROJECT SUMMARY
G-quadruplex (G4) is a non-canonical secondary structure that forms in guanine rich segments of DNA and RNA.
Bioinformatics revealed over 375,000 potential G4 forming sequences (PQS) located throughout the human
genome. When transcribed, such PQS can give rise to two structures, RNA G4 (RG4) in mRNA and R-loop, an
RNA:DNA hybrid structure that results from annealing of nascent G-rich RNA and C-rich template DNA. Recent
study revealed that R-loop structures overlap with PQS, suggesting a divergent role played by each element.
RG4s are found most densely in the 5’UTR of many genes, including key oncogenes, while R-loops are enriched
near the promoter region. Despite the mounting evidence that both RG4s and R-loops are important factors in
gene regulation, it remains uncertain how they regulate transcription and translation. Furthermore, both the RG4
and R-loop structures can be modulated by proteins that specifically target them, which adds to the complexity
of their impact in gene regulation. Importantly, these specific proteins are hallmarks of cancer, emphasizing the
role they play in oncogenesis. I propose to investigate RG4s and R-loop in vitro and in cell-based systems to
address the following questions: 1) How does the PQS sequence composition and position encoded in 5’UTR
segment of DNA regulate transcription and translation? 2) What is the contribution of R-loop and RnaseH1 (R-
loop digesting enzyme) in transcription and translation? 3) What is the contribution of RG4 and DHX36 (RG4
resolving helicase) in transcription and translation? I will use a combination of single molecule techniques (single
molecule FRET, single molecule PIFE, and super resolution cell imaging) and ensemble assays (dual-luciferase
assays, ensemble transcription assays, real-time G4 formation measurement, EMSA, and ribosome profiling) to
achieve the proposed aims. My proposed research is bolstered by collaborations with experts in the fields of G4
mediated cellular processes (Patricia Opresko), G4 helicases (Adrian Ferre-D’Amare), super resolution
microscopy (Taekjip Ha), and translation (Rachel Green) (see support letters). Professional development
opportunities along with strong collaboration and mentorship will enable me to become a productive principal
investigator in the future. My plan to become an expert in single molecule techniques in addition to honing my
scientific writing and communication skills will set me apart from others seeking competitive postdoctoral
positions.

Public health relevance
NARRATIVE Oncogenes have a high enrichment of potential G-quadruplex forming sequences in the 5’UTR, yet the role played by the G-quadruplexes in oncogenesis is unknown. The proposed project utilizes combination of ensemble and single molecule techniques to investigate how 5’UTR G-quadruplexes (sequence and position variants) regulate transcription and translation. Elucidating the mechanism by which G-quadruplexes impact gene regulation will lead to understanding of the role they play in oncogenesis.